The TAIL-PrEP Study: Acceptability and Feasibility of a Tailored Adherence Intervention for safe discontinuation of Long-acting PrEP

Abstract
Oral PrEP is highly effective but underutilized: only 25% of individuals eligible for PrEP in the US have a
prescription. Recent approval of cabotegravir-LA (cab-LA), a long-acting injectable integrase inhibitor and the
first long-acting injectable form of PrEP, presents an opportunity to increase uptake. However, the long and
variable half-life of cab-LA across different individuals after discontinuation (called the “tail”) poses an
implementation challenge. During the tail, cabotegravir levels decline to levels that are no longer protective but
remain in sufficient concentration that if a patient were to acquire HIV during this time, they could select for
integrase-inhibitor resistance. This concern about the tail presents a barrier to providers prescribing cab-LA,
limiting the potential for cab-LA to contribute to End the HIV Epidemic targets and exacerbating disparities in
PrEP uptake and HIV infection. To mitigate the risk of acquiring drug-resistant HIV infection during the tail,
individuals are advised to use oral PrEP for 12 months or longer after discontinuing cab-LA and for as long as
they have ongoing risk of becoming infected with HIV. However, these recommendations are difficult to
implement because (1) clearance of cabotegravir is highly variable across individuals with no clear predictors of
duration until clearance and (2) individuals may misjudge their HIV risk during the tail, leading to a lack of HIV
prevention when individuals are at greatest risk for drug-resistant HIV infection.
With input from community stakeholders, New York City Department of Health and Mental Hygiene (NYC
DOHMH), clinicians, and patients, we designed TAIL-PrEP, an adherence intervention based on behavioral
economic principles, to support patients in remaining on oral PrEP for as long as they need to in order to prevent
drug resistance. TAIL-PrEP brings a personalized medicine approach to adherence, by using biomarkers to
provide an objective, individualized measure for the minimum duration for which oral PrEP is indicated. It is
designed with scalability in mind, allowing patients and their providers to monitor cab-LA drug concentrations
and tenofovir adherence with samples self-collected at home. Additionally, TAIL-PrEP was designed using an
Implementation Research Logic Model that articulates the ways in which the intervention is hypothesized to
impact the desired outcomes (e.g., mechanisms of action), the implementation strategies by which the
intervention will be delivered, and the outcomes that will be assessed.
The TAIL-PrEP Study will evaluate the acceptability and feasibility of the intervention in a small pilot. Study
results will be shared first with local, then national stakeholders, and iteratively refined based on their feedback
to increase the likelihood that the intervention will be acceptable and feasible in diverse clinical contexts serving
diverse patient populations. At the end of this project, we aim to have (1) a refined TAIL-PrEP intervention and
implementation strategy; and (2) sufficient acceptability and feasibility data to lead to an application for an R01
to support evaluation in a multi-site intervention implementation and effectiveness hybrid-design study.

Public health relevance
Project Narrative Potential for the impact of a long-acting injectable PrEP agent (called cab-LA) on ending the HIV Epidemic is tempered by the fact that there are limited resources and information to guide patients and providers on how to safely stop injections. Patients and providers need support on how to cover the highly variable drug tail when cab-LA concentration remains quantifiable but no longer protects against HIV infection, because without a plan: (1) patients may be vulnerable to acquiring and transmitting integrase-resistant HIV, and (2) providers may be unwilling to prescribe cab-LA to the patients who could benefit most from this new prevention tool. To address this significant challenge, we will assess the feasibility and acceptability of a theory-driven, dual-drug monitoring adherence intervention informed by behavioral economics that we hypothesize will (1) support patients to stay adherent to oral PrEP until cab-LA has cleared their body, and (2) reassure providers through dual-drug monitoring leading to increased willingness to prescribe cab-LA.